TRACKING OF BONE MASS DURING CHILDHOOD AND ADOLESCENCE

The objective of this study is to assess tracking of bone mass during childhood and adolescence. Specifically, we will estimate the degree of tracking over 1 and 2 year intervals in girls between 3 and 17 years of age. Annual measurements bone mineral content and density will be measured by dual energy x-ray absorptiometry. A total of 300 girls will be followed for 3 years. To date, baseline measurements have been obtained on 229 girls. This study will lay the foundation for a longer- term longitudinal study of tracking in bone mass in children.